Measuring Language Competence in AA Children who are High Dialect Speakers

PROJECT SUMMARY
There is no change from the Project Summary submitted in the parent application.

Public health relevance
PROJECT NARRATIVE There is no change from the Project Narrative submitted in the parent application.